Mesenchymal Cell Dysfunction in Fibroproliferative Lung Disease

Abstract
Progressive fibrosis is a cause of major morbidity and mortality as best exemplified by idiopathic pulmonary
fibrosis (IPF). The molecular mechanisms that control unremitting lung fibrosis remain poorly understood. During
the funding period of this PO1, we identified an invasive fibroblast phenotype that appears to be an important
feature of unremitting pulmonary fibrosis. We have identified invasive fibroblasts that contribute to severe lung
fibrosis in mouse and human, and the invasive phenotype requires HAS2, CD44, and beta-arrestins. Fibroblast
lineage-tracing studies identified that T box gene 4 (Tbx4)-lineage mesenchymal progenitors are the
predominant source of myofibroblasts in injured adult murine lung. To further analyze the genetic regulation of
fibroblast invasion, we performed RNA-seq analysis of a set of invasive and noninvasive fibroblast samples from
IPF patients. Unexpectedly, we found that several immune molecules including both checkpoint PD1 ligands,
PD-L1 (CD274) and PD-L2 (CD273), are significantly upregulated preferentially on invasive human fibroblasts.
The Programmed Death-1 (PD-1, CD279) pathway is a homeostatic mechanism of the immune system that
prevents autoimmunity and uncontrolled inflammation, and it is also used by cancer cells to escape from immune
surveillance. This is an intriguing and novel discovery, particularly in light of the FDA approval of the multi-
tyrosine kinase inhibitor nintedanib for IPF, a drug that was initially developed for cancer. A paradigm has evolved
that the pathobiology of IPF is more similar to cancer than to chronic inflammation. However, the role of PD-
1/PD-L1 in lung fibrosis is unknown. Our preliminary studies revealed that PD-L1 regulates fibroblast adhesion,
migration and invasiveness. We found that the focal adhesion components including focal adhesion kinase (FAK)
and Rho/ROCK are significantly up-regulated. More recently, in collaboration with Dr. John Belperio at UCLA,
PI on Project 3, we have also identified invasive fibroblasts in patients suffering from chronic lung allograft
dysfunction (CLAD), which is the major cause of morbidity and mortality following lung transplantation. We
propose to perform a similar approach in these cells with the hope of identifying new targets for therapy of CLAD.
We have begun to examine the regulation of PD-L1 and found that PD-L1 was down-regulated by p53 in lung
fibroblasts. In contrast to the immune checkpoint genes, p53 is markedly down-regulated in invasive fibroblasts,
similar to that in cancer cells. Much attention has been paid to epithelial p53 expression and function in fibrosis,
but the role of p53 in fibroblasts has not been thoroughly investigated. It appears that p53 may have a role not
only in preventing epithelial apoptosis, but also in fibroblast invasiveness, thereby providing two distinct
mechanisms in the pathogenesis of pulmonary fibrosis. Taken together, we hypothesize that loss of p53 up-
regulates immune checkpoint genes in lung fibroblasts, leading to the activation of PD-1 ligand-mediated evasion
of immune detection, focal adhesion and cell invasiveness.

Public health relevance
Narrative The molecular mechanisms that control tissue fibrosis remain incompletely understood and effective therapies for severe pulmonary fibrosis are lacking. In this proposal, we will test our hypothesis that loss of p53 may up- regulate immune checkpoint genes in lung fibroblasts, leading to the activation of PD-1 ligand-mediated evasion of immune detection, focal adhesion and cell invasiveness. Achievement of the goals of this application will result in a completely novel approach to the treatment of lung diseases.